CAREER DEVELOPMENT IN PEDIATRIC AND MEDICAL ONCOLOGY

DESCRIPTION (Applicant's Description): The applicants are requesting funds for a research career development program in Pediatric and Medical Oncology at the Fred Hutchinson Cancer Research Center and the University of Washington. The Career Development Program will interface with their Pediatric and Medical Oncology Research Training Programs at the Fred Hutchinson Cancer Research Center (FHCRC) and the Departments of Pediatrics and Medicine at the U n i versity of Washington (UW) with the goal of developing clinical investigators. It will support physicians who have completed three years of fellowship training in the pediatric or medical oncology training programs. Prior to entry into the program, fellows will have acquired clinical skills and basic laboratory tools of modern biology. Those most qualified and motivated to enter into investigative endeavors in clinical research will be selected. During their two years supported by the career development program, trainees will gain the tools and experience necessary to conduct clinical research, translate their findings to patients, and generate sufficient data to help establish independent research careers. The aim of their projects will be to contribute new and useful information relevant to clinical oncology and to develop the clinical research capabilities of the trainees. Clinical research p r ojects in the areas of bone marrow transportation, immunology and immunotherapy, normal and malignant hematopoiesis, human immunogenetics, gene therapy, and molecular pharmacology and molecular biology, as well as other programs, will be used for training. This program involves the laboratory and clinical research facilities of the Fred Hutchinson Cancer Research Center and the University of Washington, and the clinical facilities of the Division of Hematology-Oncology at the Children's Hospital and Medical Center, the primary clinical pediatric service of the University of Washington.